West Africa Center of Excellence for Data Science Research Education

Project Summary/Abstract
Sub-Saharan African countries are severely affected by the world’s most devastating infectious diseases,
including malaria, HIV/AIDS, tuberculosis, neglected tropical diseases, and is experiencing an unprecedented
increase in noncommunicable diseases, including cancer, cardiovascular diseases, and diabetes. In the past
decades, public health, biomedical and clinical research have also increase significantly with support from the
National Institutes of Health (NIH) and other partnership. This partnership has contributed a breadth of diverse,
large, and complex clinical and biomedical data sets, providing unique opportunities for applying data sciences
for discoveries that may catalyze innovation in diagnosis, and therapy of diseases of public health interest in the
region. However, a critical gap is that these data remain under-exploited due to limited human resources with
skills and expertise in data sciences to harness the value of these data to have a meaningful public health impact.
The overall objective of this UE5 Research Education Program involving the University of Sciences,
Techniques and Technology of Bamako (USTTB) and Gamal Abdel Nasser University of Conakry, Guinea
(UGANC) with support from Tulane University is to build interdisciplinary teams across multiple African
institutions capable of using innovative quantitative and analytical approaches to generate and apply new
knowledge from large or complex sets of data in the subregion through the following specific aims: 1)
Strengthen existing institutional research training programs to address the needs for optimal use and
processing of large and complex data sets using advanced data science approaches. We will provide faculty
enhancement training and develop advanced data sciences courses for enriching curricula of existing Masters
and PhD programs and professional development short-term training (medical residents, public health, clinicians
and junior researchers); 2) Develop and deliver datathon (i.e., data analysis hackathon) training that
involves multidisciplinary collaboration among researchers, data engineers, machine-learning experts,
statisticians, and other information scientists. Datathon participants will perform team-oriented approaches in
response to research questions of interest in the area of infectious disease outcomes (e.g., malaria, NTDs,
TB/HIV, or emerging infectious diseases) and develop solutions in group settings; and 3) Produce a critical
mass of trained public health professionals, disease control managers, and researchers capable of
working closely together to use data sciences to refine and guide control interventions most effectively
through short courses sequence focused on hands-on advanced data science. Developped short-term training
sessions and modules through a multifaceted approach to facilitate partnership among researchers and local
faculty and stakeholders for future implementation of data sciences research.

Public health relevance
Project Narrative Innovative public health research, such as data science approaches are critical to address challenges related to the burden of communicable and noncommunicable in Sub-Saharan African countries. However, there is limited human resources with skills and expertise in data sciences to harness the value of a breadth of diverse, large, and complex clinical and biomedical data sets generated through an increasing international partnership. This UE5 proposal will build interdisciplinary teams across multiple institutions capable of using innovative quantitative and analytical approaches to generate and apply new knowledge from large or complex sets of data in the subregion. The proposal will strengthen existing institutional research training programs to address the needs for optimal use and processing of large and complex data sets using advanced data science approaches. It will facilitate partnership among researchers and local faculty and stakeholders for future implementation of data sciences research.